Substance Abuse Epidemiology Training Program (SAETP) at Columbia University

Substance use and substance use disorders (SUD) constitute major public health problems due to their associated disability, comorbidity and mortality. Addressing these burdens requires cutting-edge public health research conducted by scientists of the highest caliber. In 2012, the Substance Abuse Epidemiology Training Program (SAETP) at Columbia University Irving Medical Center (CUIMC) in New York City was established
with the objective of training talented young scientists to become the next generation of leaders in substance abuse epidemiology. Through competitive applications, SAETP has successfully attracted a talented group of fellows that have been productive and successful during and after training. Completed SAETP fellows have attained prestigious research positions in academic research settings and many have obtained their ownindependent funding. We now propose the next 5-year renewal cycle for SAETP. SAETP exists in a very rich, stimulating academic environment, offering unparalleled medical center resources. With its specialized training for substance abuse epidemiology careers, SAETP is unique at CUIMC. Dr. Deborah Hasin and Dr. Silvia Martins, SAETP MPIs, are internationally recognized substance abuse epidemiologists with extensive successful mentoring experience. The 24 other SAETP faculty members offer interdisciplinary expertise (e.g., epidemiology, psychiatry, psychology, sociomedical sciences, biostatistics, nursing) and have outstanding records of publishing, funding, collaborations, and mentoring productive and successful trainees. At any given time in the renewal, SAETP will continue to train 4 pre-doctoral fellows for training periods of 3-5 years each, and 4 post-doctoral fellows for training periods of 2-3 years each, a number that has worked well in the current cycle. Fellows will be selected based on their prior productivity, accomplishments, and commitment to substance abuse epidemiology careers, and fit with the SAETP program.. SAETP will provide broad, intensive training in substance abuse epidemiology and related areas; depth in one or more areas of specialization; cutting-edge methodological skills, development of conceptual skills, including formulation of key research questions and testable hypotheses, and the ability to design and conduct high-quality substance abuse epidemiology studies. Fellows will receive mentoring and participate in many training components, e.g., weekly substance abuse epidemiology faculty-fellow seminars, research internships, academic courses. Fellows will also receive training in the Responsible Conduct of Research and Rigor and Reproducibility in Research. SAETP training will enable fellows to publish papers, hone presentation skills, learn to write fundable grant proposals, and enhance collaboration and leadership skills. This rigorous, enriched training will prepare a new generation of outstanding researchers to address the epidemiology of substance use and SUD, which are urgent public health problems.

Public health relevance
Substance use and substance use disorders, which have increasing prevalence in the US, place a huge burden on individuals and society. Addressing this burden requires state-of-the-art epidemiologic research to detect and monitor trends, and to identify risk factors in order to inform interventions to reduce the toll of substance abuse on individuals and society. Since its start in 2012, the Substance Abuse Epidemiology Training Program (SAETP) at Columbia University Medical Center has been training productive, successful junior substance abuse epidemiologists; in a renewal cycle, we propose to continue such training, making the public health relevance of this program very strong.